Dysfunction of microglial proteostasis drives neuroinflammation and cognitive decline following pneumonia

PROPOSAL SUMMARY / ABSTRACT
Multiple lines of clinical evidence demonstrate a link between pneumonia, cognitive impairment, and dementia
in the elderly. The mechanisms underlying this susceptibility, however, remain unclear. In this proposal, we will
test the hypothesis that loss of proteostasis in old microglia results in a persistent maladaptive response to
immune insult that precludes recovery of neuronal plasticity and cognitive capacity after severe viral
pneumonia. Toward this aim, the Budinger/Misharin Laboratory has developed a murine model of pneumonia
using influenza A virus, which we will use to compare cognitive recovery in young and old animals and models
of Alzheimer's disease (AD). Our preliminary transcriptomics data from bulk brain tissue and flow-sorted
microglia suggests that microglia in old animals develop significant proteostasis dysfunction, and adopt a pro-
inflammatory phenotype in the steady state. This is exacerbated by persistent activation of the integrated
stress response after pneumonia, in addition to aberrant increases in antigen presentation and gliogenic
markers. We hypothesize that microglial proteostasis deficits in aging and in AD may impair homeostatic
function and “prime” an aberrant response to infection, leading to neurodegeneration and cognitive impairment
after insult. In this proposal, we will first test whether microglia are necessary for the initiation of cognitive
impairment in murine models of aging and AD, using pharmacological ablation. We will then determine whether
cognitive deficits after pneumonia in aging and AD can be rescued through inhibition of the ISR with the small-
molecule inhibitor ISRIB. Finally, we will determine whether activation of the ISR in microglia, alone, is
necessary or sufficient for the precipitation of cognitive impairment in AD using genetic manipulation of the ISR
effector Atf4. This study will help to critically evaluate the role of infection in the development of sporadic
dementia, and may aid in the development of prophylactic therapies for age-related cognitive impairment.

Public health relevance
PROJECT NARRATIVE Clinical findings have demonstrated that risk of cognitive decline and dementia is elevated nearly two-fold in the elderly following pneumonia infection. As the elderly population in the United States continues to expand, and SARS-CoV-2 continues to target elderly populations, this is now a growing public health concern. We therefore aim to develop the first animal model of this phenomenon, to test the hypothesis that proteostasis dysfunction in microglia in aging and in early Alzheimer's disease “primes” microglia in the central nervous system for an aberrant response that can lead to cognitive decline and dementia.